Modulating electro-chemotactic stimuli and Top2b-mediated pathways to promote integration of cone progenitors

PROJECT SUMMARY Retinal degeneration leads to progressive vision loss in millions of Americans. Promising cell replacement therapies have transplanted stem and progenitor-like cells (STLC) to replace damaged photoreceptors, but have yet to achieve the synaptic integration needed to restore Human vision. This deficit is largely because donor cells must maneuver a complex retinal environment, whose physio-chemical cues of damage impact donors in ways that remain underexplored. This project will create a predictive microfluidic-eye explant model to evaluate the extent to which external electro-chemotactic (EC) stimuli can guide the integration of photoreceptor replacements via a DNA topoisomerase II beta (Top2b) pathway. The research group has collectively demonstrated that STLC migrate large distances in response to external EC stimuli and used bioinformatics to target Top2b-regulated pathways as, both, significant to EC-induced migration and critical to synapse formation in the photoreceptor layer. Studies will first determine the range of clinically-applicable EC fields able to produce the directional migration of cone progenitors and correlate several metrics of cone cell movement with its Top2b expression. Experiments will then identify mechanistic roles of Top2b in retinal repair via quantitative pairing of EC-induced cell integration with genetic cell manipulation. Upon completion, the project will have developed a tunable, experimental model to manipulate the migration and synapse formation of STLC groups within retinal tissue using external fields. This translational system will facilitate the screening of new therapeutic targets, strategies and compounds to advance transplantation outcomes.

Public health relevance
PROJECT NARRATIVE Promising cell replacement therapies have transplanted a variety of donor cells to replace damaged photoreceptors, which contribute to progressive vision loss in growing numbers of Americans. However, the roles of the retinal microenvironment on the behaviors of transplanted cells remain largely unexplored despite evidence that cues from host retina influence donor cell processes. This project develops a predictive, experimental model to guide donor cell integration using external, combinatory electro-chemotactic fields and correlate consequent donor cell behaviors with Top2b-regulated pathways that mediate migration and synapse formation.